Deciphering Borrelia burgdorferi RpoS regulatory networks in ticks and mammals

Abstract
Borrelia burgdorferi (Bb) is maintained in nature within an enzootic cycle involving a mammalian reservoir host
and a tick vector. To sustain this dual-host lifestyle, Bb must remodel its transcriptome as it shuttles between
these two host milieus. The RpoN/RpoS pathway is central to borrelial gene regulation. In addition to
upregulating genes required for tick transmission and mammalian infection, this pathway represses tick-phase
genes, hence its designation as the `gatekeeper'. Activation of the spirochete's other major pathway, Hk1/Rrp1,
results in synthesis of the second messenger c-di-GMP, which is required for survival in ticks. c-di-GMP exerts
its regulatory effect via the effector protein PlzA. Using a novel transcriptomic approach, TBDCapSeq, we
compared the RpoS regulons during the nymphal blood meal and mammalian host-adaptation. These analyses
established unequivocally that the contours of the RpoS regulon differ dramatically during the tick and
mammalian phases and that RpoS-mediated repression occurs exclusively within mammals. Unexpectedly, we
found that deletion of BosR in an IPTG-inducible rpoS strain diminished expression of RpoS-upregulated genes
and abrogated RpoS-mediated repression. Thus, in addition to its well-recognized function as a cofactor for
RpoN-dependent transcription of rpoS, BosR also plays an essential downstream role modulating promoter
recognition by RNAP-RpoS. Using a Bb strain that synthesizes c-di-GMP constitutively, we made the intriguing
observation that liganded-PlzA (PlzALig) exerts a `brake' effect on RNAP-RpoS, antagonizing RpoS-mediated
repression and diminishing transcription of RpoS-upregulated genes. Remarkably, the effect of PlzALig on RNAP-
RpoS mirrors BosR-deficiency. These findings lead to our central hypothesis that PlzALig and BosR determine
the contours of the RpoS regulon by exerting reciprocal effects on RNAP-RpoS. In Aim 1, we will determine how
DNA binding by BosR shapes the RpoS regulon and investigate the mechanism underlying RpoS-mediated
repression. Experiments in Aim 2 will investigate two possible mechanisms to explain the PlzALig brake. Lastly,
in Aim 3, we will assess the contributions of other regulatory factors to modulation of the tick- and
mammalian-phase RpoS regulons. Our long-term objective is to develop a holistic understanding of how the
RpoN/RpoS regulatory networks orchestrate gene expression to sustain Bb in nature.

Public health relevance
Borrelia burgdorferi (Bb), the causative agent of Lyme disease, is maintained in nature by an enzootic cycle that involves a tick vector and a mammalian host. Since its discovery, the RpoN/RpoS pathway has gained widespread recognition as a central player in gene regulation. The experiments in our proposal will define more precisely how BosR and PlzA modulate transcription by RNA polymerase-RpoS and assess the contribution of other regulatory factors to modulation of the tick- and mammalian-phase RpoS regulons.